UTIL OF HIGHLY SENS TSH-IRMA ASSAY FOR MONITORING SUPPRESSION OF PIT/AXIS

This is a randomized prospective study to compare the efficacy of fully suppressive vs partially suppressive doses of 1-thyroxine in shrinking abnormal thyroid tissue, and to evaluate changes in bone density which may occur in patients taking suppressive doses of 1-thyroxine, and to determine if any documented adverse effects of 1-thyroxine on peripheral organs can be minimized by using partially suppressive, rather than fully suppressive doses of 1-thyroxine.